micro-PET/CT system for preclinical molecular imaging

Project Summary. This proposal requests funds to acquire a new micro Positron Emission and Computed
Tomography (micro-PET/CT) imaging system for investigators conducting cutting-edge preclinical molecular
imaging research at Emory University. PET is a medical technique that creates images of biochemical processes
occurring in vivo, where radioactive molecules (also known as PET ligands) are injected and the distributions of
those molecules are measured using a PET scanner. The unique detection physics of PET permit the creation
of images that are fully quantitative and capable of assessing metabolism, protein binding, receptor density,
blood flow, cellular synthesis and other biological processes. Emory has a well-established Center for Systems
Imaging Core (CSIC), which is an NIH-supported core laboratory with a comprehensive supporting
radiochemistry facility including discovery laboratories, radiopharmacy and an on-site cyclotron. The CSIC
strives to develop and apply breakthrough imaging approaches in translational and clinically meaningful ways.
Our continuing success relies on the integration of new and emerging technologies into our existing research
imaging platform; however, our current small-animal PET/CT scanner is obsolete and at high risk of becoming
inoperable due to service and parts discontinuation of the manufacturer.
We propose to purchase a state-of-art PET/CT imaging system, which offers an innovative, high-
performance with improved spatial resolution and sensitivity at lower cost. One integrated micro-PET/CT platform
with precision machining of the animal bed assure smooth transition while fully automatic image co-registration
fuses images with micrometer precision. Physiological monitoring of rats and mice is assured through respiratory,
body temperature and cardiac gating. The proposed imaging system will be housed at the CSIC and managed
by a team of expert technical faculty and administrative staff that are highly experienced in operating NIH-
supported core facilities. A complete organizational plan is presented with strong institutional support to take full
advantage of the proposed instrument and core resources. The new micro-PET/CT will be an important resource
not only for many currently funded biomedical imaging research projects, including studies on neurodegenerative
disorders and brain function, cancer, cardiovascular and infectious diseases, but also become an invaluable
imaging platform to develop new innovative, interdisciplinary and translational research at the Emory research
community, as well as at other institutions in the greater Atlanta area.

Public health relevance
Project Narrative This proposal requests a new small-animal positron emission and computed tomography (PET/CT) to support translational, disease-focused, and basic science molecular imaging research at Emory University. The current Inveon PET/CT system at Emory University is obsolete and at high risk of becoming inoperable due to service and parts discontinuation of the manufacturer. The new system will be operated and managed through the Center for Systems Imaging Core and continues to support innovative and NIH-funded preclinical molecular imaging development in the study of neurology, cardiology, oncology and infectious diseases in the greater Atlanta area.